Limited Competition: Continued Follow-up of Subjects and Initiation of a Second Case-control Cohort in The Environmental Determinants of Diabetes in The Young Study (TEDDY)

PROJECT SUMMARY/ABSTRACT
This proposal aims to leverage and enhance existing resources to create a robust, interoperable
set of CDEs that will facilitate better understanding, characterization, and treatment of T1D. The
participating T1D consortia will continue to support, enforce, and sustain the adoption and
compliance of the developed CDEs. Our sustainability plan includes promoting community usage,
publish our findings and share outcomes with the T2D community. All established CDEs will be
submitted to the NIH CDE Repository for endorsement. This collaboration will ensure that any
existing relevant CDEs registered by other Institutes and Centers (ICs) are identified and reused
where possible. New CDEs will be created with concept annotation aligning with the semantics of
CDEs from other NIH projects, optimizing interoperability.

Public health relevance
NARRATIVE Type 1 diabetes (T1D) is a complex, polygenic autoimmune disease that results from the immune destruction of insulin-producing cells. There is extensive heterogeneity in which AABs are expressed and at what levels, along with variations in donor/family information and Social Determinants of Health (SDoH), which significantly influence disease prognosis and outcomes. This project aims to define and harmonize common data elements to support interoperability and to enforce, and sustain the adoption and compliance of the developed CDE.